SmartStim, a novel implantable neuromodulation system to cure chronic pain.

Project Summary/Abstract
Chronic pain without apparent tissue damage is characterized by central sensitization at the level of spinal cord
and brain, which often results from prolonged peripheral sensitization of nociceptors, consisting of small-diameter
Aδ- and C-fiber afferents with cell bodies in the DRG. Our goal is to develop a novel treatment for chronic pain
that provides sustained relief by targeting the root cause: reversing the underlying neural sensitization. The
objective is the translational development of a combined device/drug treatment for chronic pain that utilizes a
SmartStim device and a long-lasting, safe nerve block reagent to synergistically achieve selective blockage of
peripheral nociceptors, especially C-fiber nociceptors. Existing neuromodulation methods, such as spinal cord
stimulation, typically mask pain by inducing paresthesia but fail to address the underlying cause, leading to
diminishing efficacy over time. The proposed SmartStim system addresses this by offering tunable and selective
transmission blockage of sensitized nociceptive afferents through a combination of electrical stimulation and
localized drug release at the level of DRGs. Prolonged suppression of peripheral nociceptive drive, especially
from C-fiber nociceptors, can potentially engage central plasticity, eventually reversing the disease state of
central sensitization. Additionally, the SmartStim system employs similar mechanical design and implantation
methods as conventional DRG stimulators and also provides comparable paresthesia-based therapy to suppress
pain, making it a safe and significant upgrade over existing DRG stimulators. Three Aims are proposed. Aim 1
will develop an implantable pulse generator (IPG) to deliver two proprietary stimulation protocols for blocking
nociceptive afferents. Aim 2 will develop localized NaKA inhibition to enhance the therapeutic effect of DRG
stimulation in blocking nociceptive afferent transmission. Aim 3 will develop the prototype of the SmartStim
system and conduct system validation. Successful development of SmartStim will lead to a paradigm shift in
chronic pain management, offering a mechanism-based and sustainable treatment option for patients who have
not found relief with existing therapies.

Public health relevance
Project Narrative The goal is to develop and validate SmartStim, a novel implantable neuromodulation system that combines proprietary electrical stimulation of the dorsal root ganglia (DRG) with FDA-approved non-addictive pharmacological treatment for treating chronic pain. Successful development of SmartStim will offer a mechanism-based and sustainable treatment option for patients suffering from chronic pain.